Targeting immunosuppression of intratumoral CAR T cells

ABSTRACT
The clinical benefits of cancer immunotherapies, including adoptive cell transfer (ACT) of chimeric antigen
receptor (CAR) T cells, are limited when used against solid tumors. The immuno-suppressive tumor
microenvironment (TME) is enriched in cellular components (regulatory T cells, myeloid derived suppressor
cells, tumor-associated macrophages, etc) and acellular factors (hypoxia, deficit of nutrients, acidosis,
adenosine, etc) that decrease viability and tumoricidal activities of anti-tumor native CD8+ cytotoxic T
lymphocytes (CTL) and of therapeutic CAR T cells. Therapeutic neutralization of these factors and components
is challenging because of their diversity and redundancy. Instead, we aim to identify and thwart the key
mechanisms by which the TME-derived factors and conditions undermine viability and the anti-tumor activities
of CAR T cells. We will focus on TME-triggered downregulation of type I interferon (IFN1) receptor IFNAR1,
which normally supports viability and activity of native CTLs and CAR T cells. Our preliminary data show that
MAPK Activated Protein Kinase 2 (MK2) and mono-ADP-ribosyl transferase PARP11 cooperate to
downregulate IFNAR1 on intratumoral CAR-bearing T cells, leading to their inactivation and rapid cell death.
IFNAR1 loss leads to downregulation of IFN1-inducible cholesterol 25-hydroxylase (CH25H). CH25H acts to
limit the effector trogocytosis between malignant cells and specific CAR T cells. In the absence of sufficient
levels of CH25H and its product 25-hydroxycholesterol (25HC), this trogocytosis undermines the activities of
CAR T cells and exposes them to fratricidal killing. These and other exciting preliminary results suggest an
overarching hypothesis that targeting TME-driven PARP11/MK2/CH25H-dependent mechanisms that regulate
the viability and activity of CAR T cells should enhance their anti-tumor activities and increase the efficacy of
CAR T ACT. To test this hypothesis, we will determine (i) the roles of TME-induced PARP11 in inactivation of
CAR T cells, (ii) the importance of MK2 activity in suppression of intratumoral CAR T cells and (iii) the
contribution of downregulation of CH25H in CAR T cells inactivation and decreased efficacy of CAR T ACT.
Completion of these studies should gain insight into immunosuppression of intratumoral CAR T cells and
help to develop novel CAR constructs and CAR T pre-treatments as well as combinatorial approaches to
increase the efficacy of CAR T ACT.

Public health relevance
NARRATIVE Chimeric antigen receptor (CAR) T cell-based therapy revolutionized our approaches to cancer treatment. Current limitation of this transformative therapy is a poor efficacy against solid tumors because CAR T cells rapidly lose their viability and activity inside these tumors. Studies proposed here will characterize key regulatory mechanisms responsible for death and inactivation of the intratumoral CAR T and identify novel means to target these mechanisms to disrupt the immune suppressive tumor microenvironment and to increase the efficacy of anti-cancer CAR T immunotherapies against solid tumors.